Tissue Resident Immune Cells in Human Pancreas.

PROJECT SUMMARY ABSTRACT
Dr. Weisberg is a Clinical Pathologist and Physician Scientist investigating the unique immune
microenvironment within human pancreas. Immune regulation within tissues is highly dependent on non-
recirculating resident immune cells. Tissue macrophages modulate local immune function, sense metabolic
disturbances and participate in tissue repair and homeostasis, and tissue resident memory T cells (Trm)
provide localized protective immune responses and tissue immune surveillance. Populations of Trm have now
been identified in almost all tissues of the body. Human and murine studies show that Trm are phenotypically,
transcriptionally and functionally distinct compared to circulating T cells. Although core properties of Trm
common to most tissue sites have been identified, the differentiation state and functional profiles of Trm are
also shaped by their microenvironment. These tissue specific properties of Trm and how they are altered by
local stressors are less well defined. Due to the limited availability of healthy human pancreas tissue, relatively
little is known about the resident immune cells of human pancreas. More knowledge is needed about these
cells, because disruption of pancreatic immune homeostasis has severe consequences for human health,
leading to diseases with high morbidity and mortality including acute and chronic pancreatitis, type I diabetes
and pancreatic cancer. Obesity is associated with pro-inflammatory changes in pancreas and is a major risk
factor for pancreatitis and pancreatic cancer. Elucidating the mechanisms that regulate pancreas resident
immune cells and how they are influenced by metabolic stressors such as obesity may suggest novel
strategies to prevent and treat pancreatic disease. Using a resource within Dr. Donna Farber’s lab which
provides access to multiple gastrointestinal tissues from previously healthy organ donors, our preliminary
studies have already defined several unique properties of pancreatic Trm. Within pancreas, networks of CD8
Trm cluster with macrophages in the exocrine and ductal areas, surrounding but not penetrating into the
endocrine islets. The Trm are resting but with high functional capacity, and the macrophages express
mediators of both positive and negative T cell regulation. Our central hypothesis is that pancreatic Trm are
maintained in a state distinct from other sites by their local interactions with pancreatic macrophages; and due
to their residence in a key tissue that regulates and senses metabolic changes, pancreatic Trm are uniquely
sensitive to metabolic alterations such as obesity. The aims of the proposal are 1) Define the distinct properties
of Trm in pancreas compared to neighboring tissues; 2) Identify mechanisms of pancreatic Trm-macrophage
crosstalk; 3) Identify obesity-related changes in pancreas Trm functional profiles and localization. This career
development award will provide critical training and experience in human T cell immunology research, and
computational analysis of high dimensional immune data allowing Dr. Weisberg to establish an independent
translational immunology research career studying mechanisms of tissue-specific immune regulation.

Public health relevance
PROJECT NARRATIVE Immune regulation within tissues depends on non-recirculating resident immune cells such as tissue macrophages and tissue resident memory T cells (Trm), which co-exist in nearly all tissues and display distinct differentiation states and functional specializations that are shaped by their tissue microenvironments. Although pancreatic immune dysfunction has devastating consequences for human health - such as pancreatitis, diabetes and pancreatic cancer – relatively little is known about the resident immune cells of the human pancreas or their modes of regulation. This proposal will explore the hypothesis that pancreatic Trm are maintained in a state distinct from other tissue sites by their interactions with pancreatic macrophages, and they are uniquely sensitive to metabolic disturbances such as obesity, and that, by defining their tissue specific properties and modes of regulation, novel approaches to mitigate pancreatic inflammation and its consequences can be identified.